Contributions of BRWD1-mediated cohesin conversion to B cell biology

PROJECT SUMMARY
In developing B cells, and in the germinal center (GC), genomic mechanisms of diversity must be strictly
coordinated with those of proliferative selection. Failure to do so risks genomic instability and leukemic
transformation. In the bone marrow (BM), this is done by ordering B lymphopoiesis into alternating and
mutually exclusive states of either stochastic immunoglobulin gene (Ig) recombination or cell proliferation with
selection. Likewise, GC B cells are divided into three subpopulations that occupy different niches and
compartmentalize the incompatible functions of proliferation, somatic hypermutation and selection. In both the
BM and GC, transit between proliferation and DNA mutation states requires large reordering of both genomic
accessibility and transcription. In the BM, the epigenetic reader BRWD1 orchestrates the radical change in
enhancer landscapes when cells exit proliferation and initiate Igk recombination. We have recently
demonstrated that it does this by converting static to dynamic cohesin at topologically associating domain
(TAD) boundaries. Dynamic cohesin then extrudes DNA across TADs to appose promoters and enhancers for
gene activation and to contract Igk for recombination. We now provide preliminary evidence suggesting that
BRWD1 is recruited to these TAD boundaries by specialized CTCF sites flanked by DNA GAGA sequences
and that GAGA motifs are important for both BRWD1 recruitment and function. Finally, we demonstrate that
deleting Brwd1 in GCs leads to disordered subsets and diminished function. Overall, our findings support a
model in which BRWD1 orchestrates essential B cell functions, in both the BM and GC, by regulating dynamic
cohesin-mediated chromatin topology to both determine enhancer landscapes and poise immunoglobulin
genes for recombination. Specific Aims:
Aim 1. To define BRWD1 GC functions and determine if these are associated with cohesin conversion.
Hypothesis: We hypothesize that BRWD1 and cohesin conversion are used, and reused, to rewire B cell gene
topology across cell state transitions.
Aim 2: Determine the mechanisms and functional importance of BRWD1-mediated GAGA motif
recognition. Hypothesis: BRWD1 recognizes GAGA motifs and this is important for both BRWD1 chromatin
binding and chromatin remodeling.
Aim 3. Determine how the recruitment of BRWD1 and cohesin are coordinated for cohesin conversion.
Hypothesis: CTCF assembles BRWD1 with cohesin at TAD boundaries to orchestrate cohesin conversion.

Public health relevance
PROJECT NARRATIVE Across all mammalian cellular processes, three-dimensional chromatin topology, including interactions between enhancers and promoters, determine gene transcription and cell fate. In this grant proposal, we will explore how BRWD1 orchestrates chromatin topology to ensure cell integrity and determine cell fate.